Single Molecule analysis of KSHV/HHV8 DNA replication proteins

7. Project Summary
Effective antiviral therapeutics are needed for the treatment of KSHV infection. We propose to pinpoint novel
KSHV antiviral targets by identifying virus specific protein functions and conformations. This project aims to study
the molecular interactions (protein-DNA and protein-protein) that govern KSHV DNA synthesis and genome
replication using a highly specialized electron microscopy (EM) approach. Previous studies used sequence
homology between KSHV and related herpesviruses to determine conserved protein functions of the seven
essential core DNA replication genes/proteins encoded by KSHV: ORF6(SSB), ORF9(POL), ORF40/41(PAF),
ORF44(HEL), ORF56(PRI), ORF59(PF) and ORF50(RTA). However, protein sequence homologies only range
from 20-50% and thus poorly predict protein function; therefore, an ultrastructural characterization of purified
KSHV viral DNA replication proteins, individually and in concert are needed to identify their full range of functions
(Aim 1). To evaluate the in vitro activities, electron microscopy (EM) will be used to directly visualize viral proteins
and viral DNAs. Our EM approach produces qualitative data (heterogeneous protein complexes, oligomeric
state, DNA architecture) and quantitative data (DNA mapping of protein binding locations, molecular size
comparisons). The first aim of this proposal will characterize the molecular interactions and activities of a subset
of already purified KSHV DNA replication proteins. The findings will provide valuable insights into KSHV
replication and inform future studies of proteins purified from a human cell culture system to directly compare
the impact of viral protein post-translational modifications of proteins produced from insect cells with human cell
native modifications. The second aim of this proposal is focused on generating viral proteins in physiologically
relevant human cell lines. We have previously produced five of the seven KSHV replication proteins using an
insect Sf9 cell system, but commercial and lab attempts to express and purify the remaining two proteins (PAF
and PRI) from non-mammalian cells have been unsuccessful. We hypothesize that by utilizing relevant human
cell types, we will overcome the challenges of producing viral proteins in non-human cell lines and enhance the
functionality of the purified proteins (Aim 2). This in-depth molecular study of the core DNA replication proteins
will advance the general understanding of KSHV biology and gamma-herpesvirus replication and the data
generated from this proposal will provide the foundation for future proposals aimed at identifying virus specific
inhibitors to prevent KSHV infection. Finally, trainees (undergraduate and graduate students) will gain exposure
and expertise in a wide range of biochemical and molecular biology approaches while also learning unique,
highly-specialized EM techniques while completing Aims 1 and 2.

Public health relevance
8. Project Narrative Two human herpesviruses, Epstein- Barr virus (EBV) and Kaposi’s sarcoma herpesvirus (KSHV/HHV8) are known to cause several human cancers. Effective antiviral therapeutics are needed for the treatment of KSHV infection. By using specialized electron microscopy (EM) to directly visualize protein-DNA structures and protein- protein conformations our goal is to identify novel anti-viral targets.